Aging, DNA methylation, and incident cardiovascular disease in breast cancer survivors

PROJECT SUMMARY/ABSTRACT
There are nearly four million breast cancer survivors in the U.S., with projections that this figure will exceed five
million by 2030. As the number of breast cancer survivors increases, addressing the health issues women face
after their initial breast cancer diagnosis is becoming more important. Breast cancer survivors face higher rates
of cardiovascular disease (CVD) incidence and mortality than women in the general population, primarily due
to cardiotoxic cancer therapies and shared disease risk factors. Identifying high-risk CVD patients before
treatment initiation will be critical for reducing CVD morbidity and mortality as it can inform cardiac surveillance
and cancer treatment decisions. However, most CVD risk models used in oncology clinics were developed for
the general population and underperform in breast cancer patients. It is unclear if existing CVD risk models can
be adapted to breast cancer patients by incorporating novel CVD-associated biomarkers specific to this
population. DNA methylation biomarkers are emerging as critical components of medical tests (e.g.,
Cologuard®), and those representing biological aging (e.g., epigenetic clocks, leukocyte composition) are
associated with breast cancer and CVD, independent of known risk factors. DNA methylation biomarkers may,
therefore, provide novel insights into CVD etiology and enhance risk prediction of breast cancer patients. A key
barrier to research on aging, DNA methylation, and incident CVD in breast cancer survivors is the limited
number of prospective cohort studies with baseline DNA methylation data and CVD events. This barrier will be
addressed by generating new blood DNA methylation data in the Pathways Study, a prospective cohort study
of 4,504 women diagnosed with invasive breast cancer between 2005 and 2013. 4,034 (90%) participants
provided blood samples in the time immediately following their cancer diagnosis. Data on cancer treatments,
CVD risk factors, lifestyle, and CVD events have been collected in the years since enrollment. Using these
resources, we propose three specific aims to evaluate our central hypothesis that biological aging metrics can
improve our understanding of CVD etiology and enhance CVD risk prediction in breast cancer patients: Aim 1)
Using causal inference techniques, estimate biological aging associations with CVD and mortality risk in breast
cancer patients; Aim 2) Assess the influence of patient and treatment characteristics and blood collection
timing on biological aging associations with CVD/mortality risk; and Aim 3) Test whether existing CVD risk
models can be modified to improve performance in breast cancer patients. Findings can improve breast cancer
outcomes by providing vital information at diagnosis that guides cardiac surveillance and cancer treatment
decisions. Critically, because blood DNA methylation can be quickly and accurately profiled in medical settings,
DNA methylation can be easily integrated into existing clinical prediction tools, thereby having an immediate
impact on breast cancer survivors’ cardiovascular health.

Public health relevance
NARRATIVE Breast cancer survivors are a growing segment of the population who experience higher rates of cardiovascular disease (CVD) incidence and mortality than women without breast cancer. Biological aging metrics derived from blood DNA methylation data are associated with both breast cancer and CVD incidence, making them an attractive solution for improving our understanding of CVD etiology and enhancing risk stratification of breast cancer patients. Findings from this proposal can improve breast cancer outcomes by providing vital information at cancer diagnosis that guides cardiac surveillance and cancer treatment decisions.